Basic Medical Research Training in Oncology

PROJECT SUMMARY
The objective of the University of Chicago Institutional T32 Training program is to provide a scientifically
rigorous and intellectually stimulating interdisciplinary research training environment for physicians who have
completed ACGME accredited residency training to prepare for research-intensive careers in academia,
government and industry. Candidates for T32 training are nationally recruited through Residency Matching
program to the Section of Hematology/Oncology within our Department of Medicine with the expectation that
candidates for T32 training will complete one clinical year funded by the hospital and then have a minimum
of two or three years of research training under the proposed training grant depending on whether they
perform patient-oriented research or fundamental basic/translational/population research. The direction of
the program – provision of multidisciplinary, structured, career development, mentoring and leadership
opportunities in cancer research – has not changed since the program’s inception, but we have continued to
evolve the program in response to a national need to develop and/or enhance research training
opportunities for individuals from disadvantaged backgrounds interested in team science and translational
research. There are several unique structural elements in the research training proposed: 1) access to a
diverse population of cancer patients; 2) training under the guidance of multidisciplinary research
preceptor(s) within a robust scientific environment that provides innovative scientific approaches, tools and
technologies; 3) specific educational pathways in the form of course work and special seminars leading to
advanced degree or certificate from any relevant unit in the University; and 4) community engagement and
service learning opportunities to accelerate progress in cancer research and promote health equity. The
33
Senior and
22
Clinical/Junior research training faculty preceptors have NIH or equivalent peer- reviewed
funding, interact on a number of collaborative research and training efforts and are well qualified to serve as
potential mentors for the six trainees per year participating in this T32 program. Our extensive inpatient and
outpatient facilities promote a comprehensive clinical training experience, while our research laboratories
allow for the acquisition of basic research skills. With significant investments in new cancer programs and
enhanced facilities, we have revamped our curriculum to offer coursework in emerging areas of cancer
research including chemical biology, proteo-genomics, metabolomics, data science, implementation science
and global oncology. In addition to leadership experience and entrepreneurship, our diverse populations in
Chicago and our global partners will provide opportunities in community engaged research to advance novel
interventions to reduce disparities in cancer outcomes. With the rapid pace of scientific advancement, a well-
trained work force as proposed remains a wise investment for the nation.

Public health relevance
PROJECT NARRATIVE The objective of the training program in Basic Medical Oncology at the University of Chicago is to provide an outstanding interdisciplinary research training environment for clinician postdoctoral fellows who have completed internal medicine residency training. Physicians completing our training program will enter the oncology work force as socially responsible citizens who are prepared to lead cancer-focused research teams in academia, government or industry.